Development of a multiomic biodosimetry panel for use during sepsis and antibiotic treatment

Program Director/Principal Investigator (Last, First, Middle): Pannkuk, Evan Lacy
Project Summary
Potential exposures to ionizing radiation (IR) in large populations exist from both intentional (terrorist actions)
and accidental (nuclear power plant accidents) sources. Novel biodosimetry assays are needed for rapid
screening (e.g. above or below 2 Gy) to separate the “worried well” from individuals needing medical care. In
addition, assays are needed within the first week to provide more accurate dose reconstruction past this initial
screening after patients have been transported to a medical care facility. These assays should provide
accurate measurements between 2 – 10 Gy in a high-throughput manner, identifying the level of medical
intervention required as well as those with a low probability of survival. Modern mass spectrometry (MS)
platforms provide tools for high-throughput biodosimetry as they rapidly measure quantitative metabolite
concentrations that can be used as a proxy for radiation injury. Metabolite panels can also be combined with
other biomarkers, such as transcripts, to increase assay sensitivity. Following a nuclear emergency, initial care
will be restricted to antibiotic (Abx) administration, decontamination, and supportive care; however, combined
injuries and infections will be inextricably linked to radiation injury. Bacterial infections of the blood
(bacteremia and septicemia) and lung (pneumonia) will be of the highest concern. As both infections and
Abx treatment will alter the host microbiome, there is a need to determine how established biodosimetry
panels will be affected in these events. Here, we propose to develop a multiomic biodosimetry panel
(metabolomic and gene expression) with increased sensitivity and specificity during dynamic microbiome
changes following IR exposure. Our objectives include refining our metabolomic profile in biofluids during
sepsis and Abx administration using a murine model and incorporating an established gene panel to
improve dose reconstruction. To achieve these goals, we will first use an established murine model of sepsis,
that utilizes intraperitoneal live pathogen injections of Klebsiella pneumonia in IR exposed BALB/c mice.
This model will more closely recapitulate a microbial infection than our previous lipopolysaccharide (LPS)
model and allow us to measure changes in metabolite and transcript levels. A cohort of mice will also be
treated with an enrofloxacin and amoxicillin cocktail after infection to determine how the altering microbiome
during sepsis and treatment affects biomarker levels. Our team is highly qualified to achieve the below aims,
which is exemplified through multiple peer-reviewed publications on radiation metabolomics/lipidomics,
bioinformatics, development of targeted MS methodologies, and toxicogenomics. These studies are needed to
complement current biomarker panels developed for biodosimetry and the variable microbiota associated
with human populations.
Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Pannkuk, Evan Lacy Project Narrative Infections will be associated with radiation injury in a nuclear emergency, of which sepsis and pneumonia will be of primary concern. Our proposed studies will develop a multiomic biodosimetry panel that will provide increased accuracy within the first week following radiation exposure in individuals with combined infection. Continuation Format Page